Aptamer mediated targeting of Fanconi Anemia oral cancer initiating cells

Abstract: We seek to use a novel cell-internalization SELEX (Systemic Evolution of Ligands by Exponential enrichment) to isolate thioaptamer-conjugated liposomal nanoparticles (TA-NP) that internalize and deliver its siRNA into the cytosol of tumor initiating cells (TIC) of oral squamous cell carcinoma, minimizing off-target delivery. In vivo delivery and release of siRNA from the endosomes to cytosol remain the two biggest obstacles for translating anticancer siRNA drugs to the clinic. Oral squamous cell carcinoma commonly known as oral cancer (OC) is the most common malignancy of head and neck with high global public health impact. Fanconi anemia (FA) is a hereditary cancer syndrome that predisposes one to OC. Evidence points to TIC as the key driver of field cancerization, resistance to therapy and disease relapse. A therapeutic vehicle that selectively targets and delivers anticancer drugs to TIC offers great promise for OC treatment. Our data and published studies show: (1).TIC is more enriched in FA-OC than sporadic OC; (2) Chk1 and CD147 promote TIC survival and chemoresistance and its overexpression contribute to poor prognosis in OC. The main goal of this proposal is to use FA- OC-TIC as target cells to develop TA- NP for the cytosolic delivery of siRNA. We hypothesize that isolated TA-NP will facilitate targeted delivery of siRNA to OC-TIC cytosol, and silence CD-147/Chk1 in OC-TIC's, disrupting their niche and rendering them chemosensitive and susceptible to elimination by chemotherapy with gemcitabine. Aims:(1): Elucidate the effect of RNAi mediated silencing of CD147/Chk1 in FA-OC-TIC; (2A): Select a list of TA-Liposomal NP (TA-NP) specific for TIC fraction of FA-OC cells, while avoiding hepatocyte uptake, using a positive and negative cell-uptake based SELEX; (2B): Determine the selected TA-NP's targeting specificity and therapeutic efficacy in in vitro and in murine OC xenografts. We will isolate ALDH+ TIC in FA-OC cell lines and examine the effects of siRNA-mediated silencing of CD147 and Chk1. (2) We will use a modified conjugate SELEX with positive and negative selections to identify OC-TIC-specific internalizing TA-NP. (3) We will validate TIC-targeting specificity and silencing efficacy of isolated TA-NP-sRNA in vitro and in murine orthotopic FA-OC xenografts. RNAi mediated inhibition of CD147 and Chk1 in OC-TIC will yield valuable insight into their potential role in the tumor propagating and chemoresistant properties of OC-TIC. The proposed TA-NP will have important clinical potentials for in vivo delivery of therapeutic and imaging agents targeting the OC-TIC.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Oral cancer is the most common malignancy of the head and neck region and is associated with a poor prognosis due frequent local and distant tumor relapse after treatment. Tumor relapse is caused by the persistence of cancer stem cells also known as tumor initiating cells. These tumor initiating cells are inherently chemoradiation therapy resistant and hence are not eliminated with the current treatments. Our project is aimed at developing a therapeutic modality that can selectively target the tumor initiating cells and deliver siRNA drugs to overcome their therapeutic resistance in order to improve disease free survival and cure rate in patients with oral cancer. __SpecificAimsTextDelimiter__ 1. Specific Aims: Oral squamous cell carcinoma, commonly known as oral cancer (OC) ranks sixth globally in cancer related mortality, with an estimated 300,000 new cases diagnosed yearly [1]. OC exhibits high mortality rates of 40-50% due to a high rate of tumor relapse at local or distant sites which is linked to the persistence of tumor initiating cells (TIC) after therapy [2-4]. Current therapies for OC do not eliminate TIC, potentially leading to OC recurrence and progression [4]. We therefore posit that development of a therapeutic delivery platform selectively targeting TIC's is critical to improving therapeutic outcomes in OC patients. CD147 (EMMPRIN) is a multifunctional protein that is critical for maintenance of the TIC niche and promotes TIC survival and chemoresistance in OC. Its overexpression in several malignancies including OC confers poor prognosis [5-10]. Silencing of the CD147 gene by RNA interference has been demonstrated, and suggests siRNA therapy as a viable option for the treatment of OC-TIC's [11, 12]. Checkpoint kinase 1 (Chk1) activity is enhanced in TIC and silencing of Chk1 confers t o them chemoradiation sensitivity [13-16]. We demonstrated that silencing of Chk1 with siRNA in highly aggressive, p53-defective and chemoresistant murine squamous cell carcinoma cells increased their sensitivity to gemcitabine [17, 18]. However, in vivo delivery remains the biggest obstacle to the translation of anticancer siRNA drugs to the clinic. The key issues are: (1) all nanoparticle siRNA carriers are cleared via the liver, leading to significant hepatic toxicity [19, 20]. (2) Cytosol- specific delivery of the siRNA payload, key to successful RNA interference, continues to be elusive [21, 22]. Aptamer targeting of nanoparticles (NP) offers an exciting solution to the delivery problem. However, to date, aptamer screening against targets has only involved screening of the aptamer library alone. The hits are then tested by conjugating them to NP, and evaluating payload delivery. Since payload delivery is not part of the screen, it is easy to envision such a process failing to yield a satisfactory targeting mechanism. Further, NP clearance by the Kupffer cells of the Reticulo-endothelial system (RES) leads to hepatocyte exposure and uptake, in turn causing severe hepatic toxicity that is independent of the targeting aptamer. The screen does nothing to reduce hepatic toxicity. Novel cell-SELEX (Systematic Evolution of Ligands by EXponential enrichment) screening methodologies can avoid this problem. We propose to create a library of thioaptamer (TA)-conjugated NP (TA-NP), and screen it against OC-TIC's, selecting the cell-internalizing TA- NP with efficient gene silencing. A negative-screen of the hits against hepatocytes, only selecting those hits that elude hepatocyte uptake, will lead to hits causing reduced hepatic toxicity. Skill with these techniques is proven in our preliminary data where we demonstrate; (1) charged-lipid + siRNA lipoplexes are efficient in delivering siRNA to OC in vitro. (2) ESTA-1, an E-selectin binding TA, is effective in targeting NP to tumor cells. A distinguishing feature of our proposal is the choice of FA-OC-TIC as a model for screening and development of OC-TIC specific therapeutic delivery platform. Fanconi anemia (FA) is a rare hereditary syndrome that predisposes to OC. The risk of OC in FA patients is ~800-fold higher than in the general population. FA-OC occurs in young patients and demonstrates more aggressive biologic behavior and poor response to chemoradiation therapy. FA patients develop multiple primary and recurrent OC as a result of field cancerization. Our data show that FA-OC's harbor 3 times more ALDH-high (ALDH+) TIC's than do sporadic OC. We will use two cell types for the negative screens: normal hepatocytes and oral keratinocytes. The overall goal of this proposal is therefore to develop and screen TA- NP for the cytosolic delivery of siRNA to silence CD147/Chk1 in OC-TIC. We hypothesize that t h e s e l e c t e d TA-NP will mediate CD- 147/Chk1 silencing in OC-TIC's, disrupting their niche, rendering them chemosensitive and susceptible to elimination by chemotherapy with gemcitabine. To test this hypothesis, we propose the following aims: Aim 1: Elucidate the effect of RNAi mediated silencing of CD147/Chk1 in FA-OC-TIC on their tumor initiating capacity and chemosensitivity. FA-OC-TIC will be isolated using Aldefluor FACS and transfected with the CD147/Chk1 siRNA using human stem cells nucleofector kit. The effect of CD147/Chk1 silencing on TIC's in vitro and in vivo tumorigenicity and chemosensitivity will be examined. Aim 2A: Select a hit list of TA-NP specific for TIC fraction of FA-OC cells, while avoiding hepatocyte uptake, using positive and negative cell-uptake based SELEX. A panel of FA-OC-TIC i n t e r n a l i z i n g TA- NP that are capable of delivering anti-GFP siRNA and knock-down GFP in OC-TIC engineered to express GFP will be isolated by cell SELEX. After sequencing and target identification, the selected TA will be conjugated to NP and used for CD147/Chk1 siRNA delivery. Aim 2B: Determine the selected TA-NP's targeting specificity and therapeutic efficacy in vitro and in murine OC xenografts. The CD147/Chk1 siRNA will be delivered using the TA-NP and evaluated for silencing efficacy of the targeted genes and the resulting effects on the TIC's tumorigenicity and chemosensitivity in vitro and in vivo.